Investigating Branched Chain Amino Acid Oxidation in Skeletal Muscle and its Contribution to Insulin Resistance

Project Summary
Branched chain amino acids (BCAAs) are essential amino acids, and their catabolism is controlled by the rate-
limiting BCAA dehydrogenase complex (BCKDH) and its inhibitory kinase BCKDK. Elevated plasma levels of
BCAAs have been associated with type 2 diabetes since the 1960s. Recent studies have suggested that
elevated BCAAs contribute to insulin resistance and the development of type 2 diabetes. However, the
mechanisms through which BCAAs drive insulin resistance remain unknown. We have previously shown
through steady-state in vivo heavy isotopic tracing that the db/db mouse model of insulin resistance and type 2
diabetes has increased BCAA oxidation in skeletal muscle and decreased oxidation in liver and adipose tissue.
High BCAA oxidation in skeletal muscle may lead to insulin resistance by a few potential mechanisms including
the promotion of fat uptake into muscle cells, as well as the inhibition of fat catabolism. Both of these
mechanisms would be predicted to cause an accumulation of lipids in skeletal muscle, leading to insulin
resistance. Based on these observations, I hypothesize that elevated BCAA oxidation in skeletal muscle
promotes the development of insulin resistance. To test this hypothesis, we have developed skeletal muscle-
specific BCKDH gain-of-function and loss-of-function mouse models. I will use a variety of techniques including
steady-state in vivo infusions of 13C-labeled nutrients and hyperinsulinemic-euglycemic clamps to determine if
increased BCAA oxidation in muscle suppresses fat oxidation and promotes systemic insulin resistance. With
these techniques and mouse models at my disposal, I will delineate specific mechanisms by which BCAAs
contribute to the development of insulin resistance and type 2 diabetes, which could lead to better, more
targeted treatment of patients with this disease.

Public health relevance
Project Narrative 1 in 10 people in the United States have diabetes, 95% of whom have type 2 diabetes, which occurs after prolonged insulin resistance. Research dating back to the 1960s has linked elevated plasma levels of branched chain amino acids (BCAAs) to insulin resistance and type 2 diabetes. We have evidence that suggests high BCAA oxidation in skeletal muscle contributes to insulin resistance, and we propose to manipulate the BCAA catabolic pathway in skeletal muscle to test its therapeutic potential in the treatment of insulin resistance and type 2 diabetes.